Chemoenzymatic synthesis and pharmacological evaluation of designer plant meroterpenoids

Project Summary/Abstract
Land plants like flowering plants and liverworts produce an array of natural products with various
biological functions. Polyketide meroterpenoids, comprising structures partially derived from terpenoid
biosynthetic pathways and partially derived from polyketide synthase biosynthetic pathways, have attracted
scientists for decades from their unique and diverse biological activity. Neuroactive plant meroterpenoids, like
phytocannabinoids from Cannabis sativa, represent a particularly exciting suite of compounds with therapeutic
promise due to their ability to cross the blood-brain barrier and engage GPCR targets. However, much of the
pharmacological data present in the literature to-date has focused on the cannabinoids, Δ9-tetrahydrocannabinol
(Δ9-THC) and cannabidiol (CBD), while minor constituents and unique analogs from other producers remain less
well studied. Lack of pharmacological data for these compounds is partly due to low accumulation of more rare
plant meroterpenoids in native producers, production in less widespread plants (i.e. specific liverwort species),
and lack of convergent synthetic routes capable of producing several analogs from one common intermediate.
Heterologous production of plant meroterpenoids has been accomplished in eukaryotic hosts (i.e. yeast) but
suffers from a pathway bottleneck caused by low catalytic activity and poor expression of plant prenyl cyclization
enzymes (e.g. THCA synthase). Bacterially derived cyclization enzymes that generate the same key
intermediate, an ortho-quinone methide, provide an attractive alternative for biocatalyst generation toward
production of plant-like meroterpenoids and their analogs. Here, I propose the development of new cyclization
biocatalysts engineered from bacterial biosynthetic enzymes for chemoenzymatic production of rare and
designer plant-like meroterpenoid products and their pharmacological evaluation to assess therapeutic promise.
This proposal aims to address issues of supply present for rare meroterpenoids with low accumulation in
native producers, generate novel, structurally diverse scaffolds using engineered biocatalysts, and test the
pharmacology (i.e. therapeutic promise) of such compounds. In Aim 1, I will engineer biosynthetic pathway
enzymes recently identified from the Moore lab, Clz9 and Tcz9, to chemoenzymatically produce meroterpenoids
with alternative regioselectivity and steric modification. While neuroactive meroterpenoids are predominantly
produced by flowering land plants, other species, like liverworts or marine bacteria, produce similar-looking
natural products. In Aim 2, I will identify new prenyl cyclase enzymes from marine bacteria and liverwort sources,
expanding the toolkit of biocatalysts for producing plant-like meroterpenoids, especially compounds with unique
stereochemistry and larger steric modifications. In Aim 3, produced compounds will be subjected to pre-
pharmacokinetics experiments to determine likely metabolic products, and both compounds and their metabolic
products will be assessed for ability to activate GPCR targets from the human brain. This research proposal will
produce rare and designer plant meroterpenoids using biocatalysts from bacterial hosts and identify which of the
produced analogs possess noteworthy therapeutic potential.

Public health relevance
Project Narrative Plant meroterpenoids are a large and diverse class of molecules producing by flowering plants, fungi, and liverworts. While the cannabinoids, from Cannabis sativa, have held the focus of the scientific community for the decades since they were discovered, alternative scaffolds from other producers studied to-date have unique pharmacology, suggesting they are interesting targets for therapeutic development. In this proposal, I describe my plan to repurpose biosynthetic pathway enzymes to chemoenzymatically produce new designer plant-like meroterpenoids, discover new enzyme cyclases capable of generating scaffolds with unique stereoselectivity and large steric modifications, and evaluate the potential of these new molecules as therapeutics through GPCR pharmacology.